Spatio-temporal Methods for Surveillance of the Opioid Syndemic

Project Summary/Abstract
In 2019, the United States Department of Health and Human Services launched the Ending the HIV Epidemic
(EHE) initiative to reduce incident infections by 75% within 5 years and 90% within 10 years. A priority
population in the National HIV/AIDS Strategy is people who inject drugs. Concurrently, the overdose crisis
remains a public health emergency. While the epidemiology of substance use is constantly evolving, the
misuse of opioids, particularly synthetic opioids like fentanyl, continues to drive the crisis. The overdose crisis
is part of a syndemic with HIV, hepatitis C (HCV), and opioid use disorder (OUD). North Carolina has been
significantly impacted by the opioid syndemic with rates of HIV infections unabated from 2012-2022 and
overdose death rates well above the national average. Understanding the opioid syndemic is of public health
importance, but this is challenging because no single data source currently observed by the public health
surveillance system fully characterizes opioid misuse at relevant spatial and temporal scales. Surveillance
data is a valuable resource, but it typically consists of health care encounters for negative health outcomes
(e.g. overdose) that only identify the portion of the population who had the event of interest recorded. These
data are also increasingly prone to misclassification, or the notion that not everyone captured in the
surveillance records belongs to the population who misuse opioids. For example, opioid overdose death counts
may include people who use stimulants but overdosed due to fentanyl contamination. When allocating opioid-
specific resources, it may not be of interest to include such misclassified individuals in the counts. Novel
statistical methods are needed to better leverage existing data and integrate multiple surveillance outcomes
while accounting for imperfect detection and misclassification. Additionally, while surveillance data are typically
available at the county-level, evaluation of neighborhood accessibility of health services requires estimates at
the sub-county level. Novel integration of electronic health record (EHR) data with surveillance data enables
high resolution small area estimates of opioid misuse prevalence. There are several methodological challenges
that will be overcome with achievement of the following aims: 1) Develop an integrated abundance model that
accounts for misclassification in surveillance outcomes to estimate opioid misuse prevalence; 2) Develop
methods for small area estimation of opioid misuse prevalence using data at multiple spatial scales including
county-level surveillance data and address-level data from the EHR; 3) Assess the current allocation of health
services in North Carolina neighborhoods to identify gaps and guide allocation of additional resources.
Successful completion of these aims will enhance surveillance of the opioid syndemic by producing accurate
small area estimates of opioid misuse prevalence that advance epidemiological understanding of the syndemic
and guide public health planning and resource allocation to prevent HIV, HCV, and overdose.

Public health relevance
Project Narrative The syndemic driven by opioid misuse, which includes opioid use disorder, fatal and non-fatal overdose, hepatitis C (HCV), and human immunodeficiency virus (HIV) is a barrier to ending the HIV epidemic and linked to significant morbidity and mortality. Accurate small area estimates of opioid misuse are critical to inform a public health response; enable data-driven distribution of resources; and optimize placement of health services for treatment and prevention of HIV, HCV, and opioid use disorder. This project develops biostatistics and data science methodology to provide small area estimates of opioid misuse by accounting for imperfect detection and misclassification in existing surveillance data sources and by the novel integration of surveillance data and electronic health record data.